A covalent strategy to profile the reader proteins of glycosylation

Project Summary/Abstract
Proteins interact with proteins, carbohydrates, nucleic acids, and lipids. These interactions govern every aspect
of life. Deciphering these interactions can contribute to the understanding of the fundamental aspects of life and
open up diverse opportunities for therapeutic intervention. While there are efficient tools to probe protein-protein
or protein-nucleic acid interactions, it’s a different story for the study of protein-carbohydrate interactions. Certain
glycan-binding proteins (GBPs) can read the codes of glycosylation (termed as readers proteins of glycosylation
for clarification), initiating downstream signaling via the interactions with the carbohydrates presented on proteins
or lipids. These reader proteins interact with glycans to regulate cell–cell communication, organism development,
tumor cell metastasis, immune surveillance, and pathogen-host interactions. Despite the critical roles of protein-
carbohydrate interactions, the lack of tools greatly hindered the efforts to study such interactions and leverage
these interactions for therapeutic purposes. To address these challenges, our lab will leverage our expertise in
organic synthesis, molecular biology, and protein science to build a versatile, small molecule-based platform to
map the reader proteins of glycosylation. In the next five years, we will first fully demonstrate the feasibility of the
proposed platform and then expand this platform to study the reader proteins of critical glycosylation including
sialylation and core fucosylation. We will also conduct structural characterization of the key identified reader
proteins. The overall goal of this research program is to decipher the protein-carbohydrate interaction code,
especially disease-related protein-carbohydrate interactions, which would lay out the foundation for the
development of therapeutics targeting carbohydrates.

Public health relevance
Project Narrative Protein-carbohydrate interactions regulate fundamental aspects of life from cell–cell communication to pathogen- host interactions, yet the lack of enabling chemical tools has greatly hindered the efforts to study these interactions and harness them for therapeutic intervention. For a given disease-related glycan, our goal is to identify its key interacting proteins and illustrate how these protein-carbohydrate interactions contribute to disease progression. Our proposed program has the potential to unlock a variety of targets for therapeutic interventions.